Mechanisms of Central Sodium Sensing and Salt-Sensitive Hypertension

PROJECT SUMMARY/ABSTRACT
Excessive dietary sodium consumption is ubiquitous in the United States and is a large contributor to
hypertension and cardiovascular disease. This is especially problematic for Black adults, who are known to have
high rates of salt-sensitive hypertension. Although the mechanisms underlying salt-sensitive hypertension are
poorly understood in humans, rodent studies document a neurohumoral component. Rodent studies have
identified specialized sodium chloride (NaCl)-sensing neurons in the circumventricular organs (CVOs) in the
brain (which lack a complete blood brain barrier (BBB)), that mediate NaCl-induced changes in sympathetic
nerve activity (SNA), arginine vasopressin (AVP), and regulation of blood pressure (BP). Recent data suggests
Na+-K+-2Cl- co-transporter (NKCC2) is not kidney specific but is in fact expressed in brain regions that regulate
whole body NaCl and water homeostasis. Interestingly, Black adults have greater basal level NKCC2 renal
activity, but it is unknown if these differences are present in sodium sensing areas of the brain. The objective of
this F32 is to determine if NKCC2 contributes toward NaCl-sensitivity in a population that is more prone to salt-
sensitive hypertension, Black adults. We seek to translate the prior rodent findings to humans by assessing
neuronal activation (using blood oxygen level dependent functional magnetic resonance imaging, BOLD fMRI)
as well as SNA, AVP, and BP during an acute hypernatremic stimulus, with and without an NKCC2 antagonist.
This will enable us to isolate the role of NKCC2 in NaCl sensitivity in Black and White adults. The overall
hypothesis is that Black adults have increased central sodium sensing and neurohumoral BP responses due to
greater NKCC2 activity in the brain. Accordingly, the first specific aim is to determine if NKCC2 contributes to
the differences observed in the neurohumoral regulation of blood pressure to acute hypernatremia between
Black and White adults. We hypothesize that the NKCC2 antagonist furosemide will attenuate the increase in
SNA, AVP, and BP during hypertonic saline infusion more in Black compared to White adults. The second
specific aim is to determine if there are differences in sodium sensing areas in the brain that are influenced by
NKCC2 between Black and White adults. We hypothesize that furosemide will attenuate the increase in BOLD
fMRI signal during hypertonic saline infusion more in Black compared to White adults. This comprehensive
assessment of sodium sensing and neurohumoral regulation of BP in response to hypertonic saline infusion,
with and without a NKCC2 antagonist, will provide novel information on the mechanisms contributing to salt-
sensitive BP. Understanding the central origins of sodium sensing and salt-sensitivity may lead to novel
therapeutic approaches to combat hypertension, a costly public health problem. Innovative and translational
approaches such as those employed in this proposal are needed to advance the field.

Public health relevance
PROJECT NARRATIVE Salt-sensitive hypertension is a costly public health problem that is more prevalent in Black adults, but the mechanisms underlying salt-sensitivity are poorly understood in humans. Rodent data suggests sodium is sensed in the circumventricular organs of the brain, which control neurohumoral regulation of blood pressure, partly via Na+-K+-2Cl- co-transporter. The purpose this study is to determine the role of the Na+-K+-2Cl- co- transporter in central sodium sensing and neurohumoral regulation of blood pressure in a population that is more prone to salt-sensitive hypertension, Black adults.